Exploring Serious Illness Communication between Latino Spanish-Speaking Older Adults and Community-Based Palliative Care Clinicians

Project Summary/Abstract
Over 5 million Americans aged 65 and older identify as Hispanic or Latino (hereafter Latino), nearly two-thirds
of whom speak Spanish at home. Compared to non-Latino White older adults, Latino older adults are also
more likely to have a serious illness, a health condition that carries a high risk of mortality and negatively
impacts a person’s daily function or quality of life. Despite high rates of serious illness, Latino older adults have
less engagement in serious illness communication (SIC) compared to non-Latino counterparts. SIC is a
process of structured, emotionally supportive conversations about prognosis, values, and priorities to inform
care decisions. High-quality SIC is associated with improved quality of life, care aligned with patient
preferences, and enhanced clinician satisfaction, while poor communication is linked to emotional distress and
lower-quality care. Multiple tools to teach SIC exist, but early research examining their acceptability and impact
was conducted primarily in White, English-speaking populations whose communication needs may not reflect
those of more diverse populations. Critical care gaps remain for SIC with Latino older adults: (a) clinicians cite
barriers to initiating SIC with diverse patients, (b) interpreters report that interpreted SIC conversations usually
go well only half of the time, and (c) clinicians receive little guidance on how to navigate SIC when the patient
and clinician have language discordance, which is more common in older adults. To fill these gaps, the
applicant has conducted initial research on the SIC experiences of hospitalized Latino Spanish-speaking
patients and inpatient palliative care clinicians. However, SIC differs between care settings and requires
different skills in community-based (clinic and home-based) settings: conversations about urgent, real-time
decisions in the hospital setting differ from conversations outside the hospital where clinicians support patients
in care planning over time with more time for rapport-building and addressing coping. The objective of this
proposal is to explore SIC needs and experiences of Latino Spanish-speaking older adults engaging in
community-based palliative care from the perspective of patients, palliative care clinicians, and professional
medical interpreters. This proposal investigates two specific aims: (1) to explore the SIC needs and
experiences of Latino Spanish-speaking older adults in community-based palliative care settings (half who had
a language-concordant visit and half who had a language-discordant visit), and (2) to explore monolingual and
bilingual palliative care clinicians and professional medical interpreters’ perspectives on the unique needs,
experiences, barriers, and facilitators with conducting SIC with Latino Spanish-speaking older adults in
community-based palliative care settings. This work will inform future clinician- and interpreter-facing SIC skill
development interventions and improve serious illness communication and care for Latino Spanish-speaking
older adults. This work will lay the groundwork for expanding SIC skill development interventions to different
clinicians (e.g., primary care and oncology) who support Latino Spanish-speaking older adults.

Public health relevance
Project Narrative Latino Spanish-speaking older adults have low engagement in serious illness communication and face critical challenges related to language barriers. This study will explore the serious illness communication needs and experiences of Latino Spanish-speaking older adults engaging in clinic and home-based palliative care from the perspective of patients, monolingual and bilingual palliative care clinicians, and Spanish-speaking professional medical interpreters. This research will inform future clinician- and interpreter-facing interventions to improve serious illness communication and care for Latino Spanish-speaking older adults.